Optimal Electrode Geometries for Efficient and Selective Deep Brain Stimulation

DESCRIPTION (provided by applicant): Deep brain stimulation (DBS) is an effective treatment for movement disorders and a promising therapy for treating epilepsy and psychiatric disorders. Despite the clinical successes of DBS, there are several aspects of the therapy that can be improved. For example, surgeries to replace primary cell batteries, or to correct misplaced leads, increase the cost and risks of the therapy. The overall research objective is to design and test novel DBS electrode geometries that increase the power efficiency and selectivity of brain stimulation. The outcome will reduce the cost and risks associated with revision surgeries, making DBS a more cost effective and safer therapy, and it will also broaden our understanding of the role of electrode geometry in electrical stimulation. The first aim is to use our biophysical model of electrical stimulation and engineering optimization to design electrodes that are more efficient at stimulating various neural elements. We will design two optimal electrode geometries for stimulating the white and grey matter regions of the brain, respectively, by coupling cable models of neurons, finite element models of electric fields, and a search heuristic, the genetic algorithm. The goal of this design optimization is to develop electrodes that are better suited to their intended anatomical target. The second aim is to measure experimentally the efficiency and selectivity of the optimized electrode designs during DBS in an animal model. We will quantify the electrical impedance of our electrode designs in vitro, and measure the in vivo stimulation efficiency and selectivity in anesthetized cats. The purpose of these experiments is to compare our results to the predications of the computational models from Aim 1, and to compare the performance of our optimized designs against the conventional DBS electrode used clinically (Medtronic model 3387). Successful execution of this research will impact the clinical efficacy of DBS, as well as other therapies using electrical stimulation, including spinal cord stimulation. In the long-term, the research will help transform electrode design from an ad hoc practice to a calculated science.

Public health relevance
Deep brain stimulation (DBS) is an effective treatment for movement disorders, including Parkinson's disease and essential tremor, as well as a promising therapy for treating epilepsy and drug-resistance psychiatric disorders. However, despite the successes of DBS, there are still several areas where the therapy can be improved, such as reducing the number of surgeries required to replace batteries and to correct misplaced leads. Developing innovative approaches to increase the efficiency and selectivity of DBS will increase battery life and reduce the sensitivity of clinical outcomes to electrode (mis) placement, respectively, which will mitigate the cost and risks of battery and lead replacement surgery.